Modulation of Tumor Microenvironment for Improved Therapy of Pancreatic Cancer

ABSTRACT
Resistance to therapeutic agents is the predominant cause of high lethality of pancreatic cancer (PC).
Inadequate and heterogeneous blood flow and obstructive desmoplastic stromal compartment are the major
impediments to the delivery and intratumoral distribution of therapeutic agents and are the extrinsic determinants
of therapy resistance in PC. Intrinsic chemoresistance of PC cells is dictated by a unique population of drug
resistant cancer stem cells. Hence selective modulation of blood flow and extracellular matrix can lead to
improved delivery of therapeutic agents into the tumors, while elimination of CSCs can improve the sensitivity of
tumor cells to chemotherapy. Elevated endothelin (ET)-1 levels and overexpression of the two ET receptors
(ETAR and ETBR) are observed in tumors. Importantly, ET-1 is a strong vasomodulator and induces
vasoconstriction via ETAR is believed to be an important contributor to the tumor blood flow heterogeneity in
tumors. Our preliminary studies indicate that the components of ET-axis are expressed in pancreatic tumors in
various components of TME including tumor cells, blood vessel and stromal cells and CSCs. Further, targeting
of ETAR with a specific inhibitor BQ123 selectively enhanced perfusion and reduced hypoxia in xenograft
PC tumors, while prolonged inhibition of ET-axis in autochthonous tumors (in KPC mouse model of PC) with
dual specificity inhibitor (Bosentan) resulted in marked inhibition of desmoplasia. We also observed that ET-
1 exerts pro-fibrogenic effects on murine pancreatic stellate cells via ETBR. We hypothesize that: “Sequential
inhibition of ETBR and ETAR can modulate stroma and perfusion for enhanced delivery, distribution and efficacy
of therapeutic agents and clinically, combination of abraxane and gemcitabine will be more efficacious with the
modulation of ET axis”. Three specific aims are proposed. Studies in Aim 1 will determine the effect of selective
ETAR and ETBR antagonists BQ123 and BQ788, on the delivery and distribution of macromolecule (ABX) and
small molecule-based (GEM) therapeutic agents. Biodistribution of radiolabeled ABX and GEM will be studied
for quantitative estimation of tumor uptake. Further, we will decipher the mechanistic role of ET-axis-mediated
cross-talk between cancer and stromal cells in PC in the context of desmoplasia. Studies proposed in Aim 2 will
determine the impact of ET-axis targeting on the efficacy of ABX+GEM both in vitro (using unique cancer cell-
stellate cell co-cultures and tumor organoid cultures) and in vivo using genetically engineered mouse (KPC)
model of PC. Finally, Aim 3 is designed to clinically evaluate the safety and perform initial screening for efficacy
of combining the ET-axis antagonist Bosentan with FDA-approved combination therapy Gemcitabine (GEM) plus
Abrexane (ABX) in PC patients. Altogether, the proposed studies will demonstrate the preclinical feasibility of
eliminating both extrinsic and intrinsic determinants of therapy resistance by targeting a single signaling axis and
clinically determine the safety of combining ET-axis antagonism with approved chemotherapeutic regimens of
PC. The data generated from the three aims will form the basis of future Phase 1/II clinical trials in lethal PC.

Public health relevance
Project Narrative Heterogeneous and inadequate blood flow and obstructive stroma in pancreatic tumor microenvironment (TME) are the critical determinants of extrinsic resistance while cancer stem cells contribute to intrinsic resistance to chemotherapy and selective targeting of these barriers can significantly enhance the delivery and efficacy of chemotherapeutic agents. We propose to undertake studies to target endothelin axis using selective and clinically-tested antagonists with a goal to improve the efficacy of GEM/ABX using preclinical models of pancreatic cancer. Further, we propose to evaluate the safety of ET-axis antagonist bosentan in combination with FDA approved combination of chemotherapeutic agents (Abraxane and Gemcitabine- GEM/ABX) in pancreatic cancer patients in a Phase I trial with a goal to generate meaningful data for a future Phase I/II clinical trials.